Elucidating the membrane properties regulating antimicrobial peptidebinding to bacterial vesicles

Project Summary
Antimicrobial peptides (AMPs), such as LL-37, have been proposed as potential next-generation
antibiotics due to their ability to bind to and disrupt the bacterial cell membrane. However, their use has
been limited by several factors, including inactivation by binding to bacterial outer membrane vesicles
(OMVs). OMVs are derived from the outer membrane (OM) of Gram-negative bacteria and therefore
have a similar membrane composition as the OM. OMVs are heterogeneous in their physical and
chemical properties, including size, charge, and lipid and protein composition, even among OMVs
produced by the same parent bacterium. Traditional methods to study protein/peptide interactions with
OMVs use bulk measurements, which result in ensemble averages that can obscure the influence OMV
heterogeneity has on these interactions. We have developed several approaches that enable us to study
protein-lipid interactions in OMVs on single-vesicle and subpopulation levels, which we will use in this
project to uncover the specific properties that regulate LL-37 binding to OMVs. We will first use liposomes
with controlled compositions to identify the roles of vesicle size, charge, lipid saturation, and LPS
composition in LL-37 binding. Next, we will use OMVs with varying sizes and charges to relate LL-37
affinity to the OMVs’ ability to protect bacterial cells from the activity of LL-37. Finally, we will investigate
how the properties of OMVs change upon exposure of the bacteria to LL-37 and how these changes
affect LL-37 binding to OMVs. Undergraduate and graduate students will be highly involved in all of the
proposed studies, and the Investigators are committed to mentoring these students to maximize their
development of technical, critical thinking, and communication skills. We anticipate that the results
generated from this project will inform the future design of more effective AMPs.

Public health relevance
Project Narrative Antimicrobial peptides, small proteins that bind and disrupt the bacterial cell membrane, have been proposed as novel antibiotics. Bacteria release vesicles that have a similar composition as their outer membrane; these vesicles have been observed to act as “decoys”, preventing the peptides from binding and damaging the bacterial cell membrane. The goal of this project is to understand the chemical and physical properties regulating antimicrobial peptide binding to bacterial vesicles and relating this to their decoy activity.